Mechanisms Underlying Muscle Development and Maintenance in Drosophila

PROJECT SUMMARY
The inability to remove protein aggregates in non-dividing cells such as neurons or muscles is a
key factor in the development and progression of neurodegenerative diseases and myopathies and
is a cellular hallmark of aging cells. While protein aggregate diseases share common features, the
molecular pathways that lead to abnormal protein accumulation cannot be explained by a single
mechanism. In protein aggregation diseases that affect skeletal and cardiac muscles, a general
trend has emerged in which aggregated proteins and organelles accumulate in regions devoid of
sarcomeric proteins. However, the cellular and mechanical triggers that initiate Z-disk
disintegration and myofiber displacement are unclear. Here we employ mutations in conserved
Drosophila genes as an entry point to uncover cellular and molecular mechanisms that lead to
protein aggregation and ultimately cellular degeneration using muscle as a model cell type.
Overall, we expect to uncover new proteins that contribute to proteostasis; identify muscle targets
of kinase activity; and define how mechanical tension and autophagy cooperate in the clearance
of protein aggregates. A powerful combination of genetic analysis, biochemistry, cell biology, and
optogenetic approaches will address these questions. We expect that this project will
fundamentally advance our understanding of how protein degradation is regulated to prevent
cellular degeneration and provide fresh insights into how protein aggregates can be effectively
cleared to reduce disease states.

Public health relevance
PROJECT NARRATIVE Non-dividing muscle and nerve cells have limited options to clear harmful biological insults. One such insult is the progressive accumulation of protein aggregates that destroys cellular function and may result in death. The overall goal of this application is to understand how cells normally clear aggregated proteins to eventually develop successful therapeutic strategies to maintain healthy cells.